Mechanisms of Right Ventricle Adaptation to Pulmonary Hypertension

ABSTRACT
This proposal builds on the scientific premise that even though female sex is a major disease modifier in
pulmonary arterial hypertension (PAH), the effects of estrogens on the right ventricle (RV) and pulmonary artery
(PA) in PAH are pleiotropic and incompletely understood. We posit that selectively activating estrogen receptor
(ER)α signaling is a more precise approach of harnessing protective estrogenic effects in the RV-PA unit that
maximizes benefit while avoiding detriment. The goal of this proposal is to identify novel and therapeutically
targetable mechanisms by which ERα exerts protective effects on all three compartments of the RV-PA unit in
PAH. We provide evidence that ERα exerts direct and indirect RV-protective effects by activating bone
morphogenetic protein receptor 2 (BMPR2) signaling to upregulate apelin in the RV and distal PA, and by
decreasing collagen accumulation in the proximal PA. We hypothesize that ERα improves RV-PA coupling in
PAH by 1) up-regulating cardiomyocyte apelin, 2) reducing proximal PA collagen accumulation and cross-linking,
and 3) preventing PA endothelial cell (PAEC) apoptosis. We propose the following aims: 1) To test whether ERα
attenuates RV pro-apoptotic signaling and improves RV contractile function via BMPR2-dependent increases in
apelin, 2) To demonstrate that ERα increases collagenase-mediated collagen degradation and decreases lysyl
oxidase family-mediated collagen cross-linking in the proximal PA, and 3) To determine whether ERα decreases
EC apoptosis in the distal PA through a BMPR2- and apelin-dependent mechanism. We generated novel ERα
knockout rats to study the role of ERα in robust models of RV failure, thus avoiding pitfalls of prior studies of sex
hormone signaling that were limited by lack of RV failure and by lack of interrogation of the entire RV-PA unit.
These studies will be complemented by investigations in BMPR2-deficient rats and apelin-deficient mice in
SA1&3, and Col1a1R/R mice resistant to collagenase-mediated collagen degradation in SA2. We will complement
our in vivo studies with experiments in cardiomyocytes and PAECs isolated from rodents with PH as well as RV
tissues and PAECs from PAH patients. The proposed studies are significant, since they will 1) identify ERα as a
critical modulator of RV function and establish a novel and therapeutically targetable ERα-BMPR2-apelin axis in
the RV, 2) establish collagenase-mediated collagen degradation and inhibition of lysyl oxidase family-mediated
collagen cross-linking as functionally important mechanisms of ERα in the proximal PA and 3) establish up-
regulation of BMPR2 and apelin as a novel mechanism of action of ERα in distal PAs. Our studies are innovative,
since they will identify ERα as a novel mediator of enhanced RV-PA coupling. Technical innovation is provided
by use of a newly generated ERα knockout rat model and a new highly selective ERα agonist. Upon completion
of the proposed studies, we will have identified the “net effects” of ERα activation in all three compartments of
the RV-PA unit and established ERα as a potent mediator of direct and indirect RV-protective effects. This will
allow for developing novel, non-hormonal therapies targeting both the RV and PA.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will determine the underlying mechanisms of how estrogen receptor  improves right heart function and pulmonary artery remodeling in pulmonary hypertension, a progressive cardiopulmonary disease that is caused by thickening of the blood vessels of the lung and that leads to premature death from right heart failure. No cure for pulmonary hypertension is available, and no specific therapies for right heart failure exist. The proposed work is relevant to the mission of the NHLBI, since it will lead to the development of novel treatments for both male and female patients with right heart failure from pulmonary hypertension or other cardiopulmonary diseases.